STUDY OF PROPENTOFYLLINE IN PATIENTS WITH ALZHEIMERS

The primary objective of this investigation is to assess the efficacy, tolerability and safety of multiple oral doses of propentifylline administered to patients with mild to moderate Alzheimer's disease.